Serum markers of glucagon sensitivity in calorie restricted humans

Calorie restriction (CR), without malnutrition, is the most robust non-genetic intervention to promote longevity
through metabolic improvements that delay aging in mice, rats, and primates. Most research aimed at
understanding the mechanism by which CR slows aging has focused on insulin and its downstream signaling
cascades. We have shown that glucagon, the counter-regulatory hormone to insulin, is essential for CR induced
improvements in lifespan, improved metabolic function, and the activation of healthspan and lifespan associated
nutrient sensing proteins. This suggests that glucagon is essential for CR to extend both healthspan and lifespan.
Although the role of glucagon receptor signaling in aging has not been heavily investigated, the rigor of this
work is supported by known effects of glucagon on downstream messengers that extend healthspan. Glucagon
increases liver AMP Kinase (AMPK) activity, cyclic AMP (cAMP), and fibroblast growth factor 21 (FGF21), which
promote healthy aging. Glucagon limits the protein kinase mechanistic target of rapamycin (mTOR) and IGF-1
bioavailability, which accelerate aging.
Highlighting the significance of this proposal, Glucagon receptor agonists are entering the market for the
treatment of diabetes and obesity and could be repurposed to promote healthy aging. To understand the potential
impact of these agonists, we propose 2 aims using samples collected from CALERIE™ trial participants, to
establish a key role of glucagon in CR improved aging. The studies proposed in this R21 create a unique
opportunity to study glucagon physiology under long-term calorie restriction in healthy non-obese humans.
Aim 1: Using samples collected from participants of the CALERIE™ trial at baseline, 12, and 24 months,
we will measure fasted serum glucagon, GLP-1, and FGF21 concentrations, hormones that modulate
aging and healthspan. We will assess glucagon sensitivity by calculating the glucagon-alanine index, an
established biochemical marker of glucagon sensitivity in humans.
Hypotheses: Serum glucagon and the glucagon-alanine index will be decreased, while serum FGF21 will be
increased in calorie-restricted people, indicative of improved hepatic glucagon sensitivity. Serum GLP-1 will not
be affected by calorie restriction.
Aim 2: Assess the relationships of glucagon, the glucagon-alanine index, GLP-1, and FGF21 with
markers of lipid homeostasis, glucose homeostasis, IGF-1 and the IGF binding proteins, and measures
of whole-body energy homeostasis in CALERIE™ trial participants.
Hypothesis: A decrease in fasted serum glucagon, the glucagon-alanine index, and increased FGF21 will be
correlated with improved lipid homeostasis (decreased serum cholesterol and triglycerides), improved insulin
sensitivity, decreased IGF-1: IGFBP1 ratio (indicative of decreased IGF-1 bioavailability), decreased body
lipid, and increased whole-body energy expenditure and lipid oxidation, independent of serum GLP-1 levels.

Public health relevance
Our preliminary data in mice suggests that glucagon is a key mediator of calorie restriction induced improvements in healthspan. The studies proposed herein create a unique opportunity to study glucagon physiology under long-term calorie restriction in healthy non-obese humans. The recent development of long-acting glucagon receptor agonists and di- and tri- conjugates that contain glucagon agonists create the potential for quickly translating this research into the clinic to improve healthspan and extend lifespan.